CAREER DEVELOPMENT PROGRAM

The goal of the career development program at M.D. Anderson Cancer Center SPORE in prostate is to develop a cadre of investigators dedicated to translational studies in human prostate cancer. The program will 1) recruit, train physicians and post-doctoral fellows to ask and answer questions that will enable them to become competent translational investigators in the field of prostate cancer. 2) To provide training in basic science principles of cancer biology that is not commonly included in clinical fellowship training or Ph.D. programs. 3) To provide specific knowledge of research in prostate cancer that will enhance the ability of the awardees to conduct innovative translational science directed toward this disease. The unique educational environment that exists at MDACC will assure that the goals will be met. Three career development awardees will be selected annually. Solicitations will be made for qualified candidates from within and outside of the institution. Given the large pool of qualified candidates within the MDACC, it is likely that most fellowship trainees will be selected from this group of investigators. Awardees will be selected from the pool of candidates who have responded to the solicitation based on objective criteria laboratory investigators that will provide comprehensive training of awardees. The mentors have been selected from a larger and diverse group of scientists and clinicians because of their interests in translational science and skill as educators and mentors. The program will be evaluated annually and modifications in the selection process of training made when appropriate.